HIV-Related Changes to the Central-Autonomic Network and Associated Risk for Hypertension

Project Summary
Despite suppression of the Human Immunodeficiency Virus (HIV) in the periphery, HIV-infected monocytes
readily traffic the virus to the central nervous system (CNS). Up-regulation of peripheral mononuclear cells
expressing pro-inflammatory cytokines leads to neurotoxic effects of the virus throughout the CNS, including
structures that support cardio-autonomic regulation. This migration and infiltration of pro-inflammatory immune
cells is also key in the pathogenesis of inflammatory endothelial vascular disease. Catecholamine signaling
plays a major role in this vicious cycle of cerebrovascular and endothelial dysfunction. Tonic elevation of
plasma catecholamines and pro-inflammatory cytokine levels are linked to reduced colony-forming capacity of
endothelial progenitor cells. Although sympathetic-parasympathetic imbalance has been reported in patients
since the beginning of the HIV epidemic and prevalence of cardio-metabolic disease comorbidity continues to
rise there has been no formal investigation into the central control of autonomic nervous system dysfunction in
HIV. This study proposes the use of functional neuroimaging to determine whether HIV and/or pre-
hypertension (pre-HTN) has an additive or interactive effect on cardiovascular (CV) reactivity via an altered
brain activity and connectivity within structures that control heart rate and blood pressure. The study aims to
examine these mechanisms at rest, during mental stress, and following anger rumination. A second goal of this
study is to determine whether a change in respiratory rate during these states may provide a cardioprotective
effect.
The candidate will assess functional brain activity through fMRI scans while simultaneously gathering data on
heart rate, continuous blood pressure, and respiratory rate. The candidate will also collect blood in order to
assess estrogen levels, and to isolate and enumerate endothelial progenitor cells (EPCs) and inflammatory
monocytes. The candidate will also learn the techniques to measure vascular endothelial function through flow-
mediated dilation of the brachial artery. Data will be collected from a total of 72 men and 72 women, aged from
35 to 65 years, during Years 1-4 of the grant. The total sample of 144 adults will be divided equally into 4
groups (36 HIV+ pre-HTN, 36 HIV+ NTN, 36 HIV- pre-HTN, and 36 HIV- NTN. This will allow the candidate to
determine whether HIV or HTN disease processes are linked to CV regulation while controlling for biologically
relevant variables such as cellular and vascular endothelial function and presence of sex hormones.
The secondary aim of this study is to assess the plasticity of this central-autonomic network by determining
whether manipulation of breathing rate can alter blood pressure and heart rate reactivity during the afore-
mentioned behavioral manipulations. Specifically, the plasticity of the baroreflex and brain networks supporting
the coordination of heart rate, blood pressure, and respiration will be evaluated within the context of HIV and
pre-HTN disease state. Data from this project will inform an R01 study focused on implementing a paced
breathing intervention to reduce the risk of HTN in persons living with HIV.

Public health relevance
Project Narrative This study is of relevance to public health because of (a) the high prevalence of uncontrolled hypertension in both the general population and persons living with HIV/AIDS, and (b) the susceptibility of neuro-immune dysfunction is elevated in persons living with HIV/AIDS and the systemic effects that are not fully understood.